INIA: Bioinformatics Core

DESCRIPTION (provided by applicant): A key objective of the INIA programs is to transform research on causes, prevention, and treatment of alcoholism. Integration of data sets and analytic methods across a broad spectrum of research is critical to success. This INIA UOI Core application is built on the success of several powerful INIA web services and data resources, including GeneNetwork, WebGestalt, and the Ontological Discovery Environment (ODE). However, our aims in this renewal are a direct outgrowth of rapid changes in genomics and neuroscience, in particular, next-generation sequencing. A theme of this core is innovation by integration. The far more pervasive use of web services in neuroscience over the last five years - Allen Brain Atlas, DAVID, ODE, Galaxy, GeneNetwork, GeneWiki, KEGG, and the Neuroscience Information Framework - represents a great research opportunity for our INIA teams. But these resources often have a steep learning curve and are difficult to use together. One of our goals is to assemble these resources together with large new data sets in a context useful to NIAAA researchers. The INIA Translational Web Services core has these aims: (1) Process, analyze, and distribute massive array and next-generation data sets for both INIA consortia; (2) Integrate INIA consortia data sets from rodents, non-human primates, and humans into GeneNetwork and significantly enhance tools for bidirectional translational queries; (3) Provide database support, training, and documentation in bioinformatics, genetics, and next-gen genomic tools to other INIA projects and cores. PUBLIC HEALTH RELEVANCE: This INIA Bioinformatics Core will provide crucial support to both INIAs for data integration. Our special emphasis is on securing and analyzing massive genomic data sets generated using arrays and next generation sequencing systems. We are also building tools to enable much more facile translation of discoveries from animal models of alcoholism to human populations and groups who are at risk.

Public health relevance
This INIA Bioinformatics Core will provide crucial support to both INIAs for data integration. Our special emphasis is on securing and analyzing massive genomic data sets generated using arrays and next generation sequencing systems. We are also building tools to enable much more facile translation of discoveries from animal models of alcoholism to human populations and groups who are at risk.